Nutrition, Exercise and phenotype Testing Core

Abstract/Summary – NExT Core
The overall objective of the Nutrition, Exercise and phenotype Testing (NExT) core of MNORC
(formerly the “Human Phenotyping Core” (HPC) is to enhance and expand the research
capabilities of MNORC investigators performing clinical and translational studies related to
nutrition, obesity, and/or obesity-related disorders in humans. The NExT core accomplishes this
goal by: 1) Provide consultation services to translational, clinical and population-based
investigators regarding appropriate assessment, testing and/or intervention approaches for their
studies related to nutrition, physical activity/exercise, obesity, or obesity-related cardio-
metabolic disorders, 2) offering expertise and infrastructure for sophisticated and standardized
physiologic testing of human subjects, including children and adults 3) providing services to
directly assist researchers to conduct their nutritional and/or physical activity/exercise
interventions in human subjects, and 4) assisting in the development of new techniques or
acquire new technologies for human metabolic phenotyping. In addition to offering a wide array
of relatively “standard” phenotypic measurements (e.g., anthropometry and body composition
(DXA, PeaPod), blood pressure, fasting blood work, oral glucose tolerance, nutritional and
physical activity assessments via self reports and objective methods (test meals,
accelerometry), and aerobic fitness assessments) the NExT core also offers several more
involved procedures to more thoroughly assess the metabolic phenotype (e.g.,
hyperinsulinemic-euglycemic clamp, isotope-tracer metabolic studies, resting energy
expenditure, skeletal muscle and adipose tissue biopsies). Before beginning their studies,
MNORC investigators may consult with expert NExT core personnel to gain insights on how the
available methodologies may help them to test their hypotheses, and potentially expand their
research questions using the tools made available to them through the Core. NExT core
personnel also consult with MNORC investigators to help optimize their study designs and their
research intervention strategies/approaches. The NEXT core also directly assists MNORC
investigators to conduct their obesity/nutritional interventions by providing services such as:
nutritional consultations with study participants, supervision of exercise training interventions,
assessment of physical activity and dietary behaviors during an intervention, as well as
assistance with conducting interventions specifically tailored to each research participant.
Overall, the services of the NExT core provide well-controlled and standardized phenotypic
testing, state-of-the-art techniques for “deeper” phenotype assessment, as well as assistance to
conduct well-controlled research interventions, all of which greatly enhance and expand on
existing approaches used by researchers in the areas of nutrition and obesity in children and
adults.